Resource Development Core

RESOURCE DEVELOPMENT CORE
ABSTRACT
Kidney health equity is a growing area of research interest in the scientific community, and new resources are
needed to ensure this work harnesses the full spectrum of research (basic, clinical, and translational) with
excellence and rigor. The Resource Development Core (RDC; Co-Directors: Joe Coresh, MD, PhD and Jen
Pluznick, PhD) of the Johns Hopkins O’Brien Center to Advance Kidney Health Equity will develop new and
refine existing resources for the conduct of basic and clinical research relevant to kidney health equity. Mature
resources will be transferred to the Biomedical Resource Core (BRC) and shared with the broader scientific
community. We will work to anticipate the needs of the research community so that we appropriately prioritize
investments and will continuously develop new ideas at Johns Hopkins as part of a dynamic incubator space
connected to national needs. The RDC will validate all new resources and share them with the BRC for
maintenance and local and national dissemination. We will leverage the strength of Johns Hopkins in kidney
health equity which spans from basic science to clinical science to epidemiology, to advance two Aims. In Aim
1, we will develop new clinical science resources to advance kidney health equity. In this aim, we will build on
a strong foundation in this area in order to innovate and build new resources including metrics of social
determinants of health designed to generate momentum towards equity, validating and interpreting proteomic
findings, and including and calibrating risk equations to social determinants of health. In Aim 2, we will
develop new basic science resources which uncover mechanisms underpinning kidney health inequity. In
Year 1, our basic science efforts will focus on establishing two key resources for the research community
focused on brain-kidney crosstalk during social stressors, and gut microbiota and sex differences. We will
work to not only make mouse models widely available through the BRC, but critically, will also develop Sample
Banks (including tissues, blood, and urine) through which researchers can easily explore these models with
minimal logistical and financial burden. In Years 2-5, we will establish new models addressing kidney health
equity and likewise transfer to the BRC both mice and Sample Banks. Together, the two Aims of this proposal
will provide new resources to propel forward research addressing kidney health equity.